Development and Application of T1rho Dispersion Imaging of Aging Muscle

Project Summary:
The overall goals of the research proposed are to develop, validate and apply innovative magnetic resonance
imaging (MRI) biomarkers that can be used to improve our understanding of the processes involved in muscle
deterioration that occurs with aging. MRI can provide not only superb depiction of soft tissue anatomy, but
appropriate MRI images can be analyzed to provide quantitative parametric maps that report intrinsic
pathological changes in tissue composition, microstructure, and function. We propose to develop novel
parametric images based on quantifying changes in R1ρ, the spin-lock relaxation rate, and its variation with the
locking field amplitude, which we term R1ρ dispersion imaging. We hypothesize this novel methodology can be
used to quantify degenerative changes in microvasculature as well as the abnormal accumulation of
macromolecules in the membranes of muscle fiber. The specific aims of this proposal are to refine and
implement novel methods of MRI data acquisition and analysis to derive quantitative parametric images based
on R1ρ dispersion and validate their interpretation in terms of pathophysiological changes via gold-standard
methods including histology, and imaging mass spectroscopy. To achieve these goals, we will perform
longitudinal MRI imaging studies of rodent models of skeletal muscle deterioration with aging. Optimized
methods will then be evaluated in a cohort of human subjects on a clinical 3T MR scanner. The quantitative
measures of microvascular changes along with macromolecular deposition will provide new information on the
progression of the characteristic changes that occur with aging and provide a new tool that may catalyze new
hypotheses and therapeutic strategies to ameliorate the effects of tissue degeneration.
During this career development award, the awardee will gain crucial training in geriatric, the biology of aging,
advanced MRI sequence development, quantitative methods of histology, and how to translate methodological
innovations into human studies. A comprehensive didactic training and career mentorship program will provide
the knowledge and experiences needed to accomplish the career goal of becoming an independent researcher
at the interface of imaging and aging study. The institutional environment at Vanderbilt University Institute of
Imaging Science is exceptional and will provide an exemplary opportunity to build a strong foundation in
developing imaging biomarkers for translational applications.

Public health relevance
Narrative This K25 application seeks support for career development that will allow the PI to gain expertise in development, validation, and clinical implementation of a new type of magnetic resonance imaging methodology that can be used to quantify microvascular changes as well as the accumulation of macromolecules in tissue that occur with aging. The PI will also undertake didactic and professional training to allow her to become an independent investigator applying novel imaging biomarkers to the study of degenerative changes in skeletal muscle tissue with aging.